Core C: Clinical Core

Clinical Core (Core C) Abstract
The overall goals of Clinical Core (Core C) are: 1) to collect data through harmonized clinical
procedures and data collection packets for the valid consensus diagnoses of Asian older
adults who have AD-dementia or AD-MCI or who are cognitively normal, 2) to develop
innovative and culturally and linguistically appropriate assessment tools to assess diverse Asian
subgroups, and 3) to provide clinical expertise related to clinical manifestations of AD to help
guide the design of ACAD research projects. For this project, we will collect information on
lifestyle and medical history and evaluate the neurological findings and cognition of older Asians
to help answer key questions about the genetics and non-genetic risk factors for Alzheimer’s
disease Asian American and Asian Canadian populations. As this is the first effort of its kind
with Asian populations, we will continue to revise our Data Collection Packet (DCP) to elicit the
needed information with high cultural sensitivity and using validated instruments where already
available. We will also validate adaptations to the instruments that we have made more culture-
fair to Asian populations.